EFFECT OF PROSTAGLANDIN E1 ON HUMAN PANCREAS ALLOGRAFT POST TRANSPLANTATION

Evaluate the effect of PGE1 on the endocrine function of the human whole organ pancreas allograft in the early post transplant period.